RFA-CE23-005 Evaluating Economic Security Policies to Prevent Firearm-Related Violence and Injuries among Black Youth

Project Summary
Firearm violence is a pervasive, preventable public health issue that disproportionately impacts Black youth
and young adults due to structural racism in the form of systematic economic disenfranchisement. Economic
security policies that address economic disenfranchisement by increasing economic security and access to
opportunities for social mobility are promising approaches to reduce firearm violence inequities among Black
youth and young adults. However, there are limited studies examining these policies as primary prevention
strategies for firearm violence, and fewer still that focus on the population most at risk of experiencing firearm
violence: Black youth and young adults. Our study proposes utilizing a mixed-methods sequential explanatory
design and community-based participatory research (CBPR) approach to collect and analyze quantitative data
followed by qualitative data that will be collected and analyzed to provide context to quantitative findings. This
sequential explanatory design will provide breadth (quantitative) and depth (qualitative) of understanding of the
effects of economic security policies on firearm violence inequities experienced by Black youth and young
adults. For our quantitative aim we will use rigorous quasi-experimental methods to evaluate the effectiveness
economic security policies (Minimum Wages, the Earned Income Tax Credit, Temporary Assistance for Needy
Families, and Supplemental Nutrition Assistance Program) as primary prevention strategies for firearm
violence among Black youth and young adults aged 10-34. For our qualitative aim we will conduct semi-
structured qualitative interviews with Black firearm injured youth and young adults aged 10-34 living in a less
generous policy environment and their primary caregiver to contextualize our quantitative findings with a more
in depth understanding of the lived experience of these policies and economic disenfranchisement. Our
research adds to the literature in important ways. We evaluate economic security policies as a society-level
intervention using a structural racism lens focusing on whether existing policies are effective for primary
prevention among those most impacted by firearm violence, Black youth and young adults, and how they are
experienced among Black youth with firearm injury and their caregivers living in a less generous economic
policy environment to better understand potential mechanisms. This study aligns with violence prevention
priorities set by NCIPC by evaluating societal-level strategies to prevent firearm violence while being guided by
principles of economic and racial equity.

Public health relevance
Project Narrative Firearm violence is a pervasive, preventable public health issue that disproportionately impacts Black youth and young adults due to structural racism in the form of systematic economic disenfranchisement. Economic security policies are promising primary prevention strategies for firearm violence that provide economic support to low-income families, including Black families, who experience persistent inequities in concentrated poverty and associated firearm violence. Our study proposes a series of complementary quantitative and qualitative analyses to evaluate both the effectiveness and potential underlying mechanisms of Temporary Assistance for Needy Families, Minimum Wage, Supplemental Nutrition Assistance Program, and Earned Income Tax Credit for preventing firearm violence among Black youth and young adults aged 10-34.